Computational Methods for Inferring Single-cell DNA Methylation and its Spatial Landscape

Project Summary/Abstract
The candidate, Wenpin Hou, PhD, is an applied mathematician and computational biologist serving as a
postdoctoral fellow of Biostatistics at Johns Hopkins Bloomberg School of Public Health (JHSPH). Her long-term
career goal is to improve clinical practice in therapy for diseases by developing computational and statistical
methods to decipher spatial and temporal gene regulatory programs using multi-omics data and implementing
these methods into developmental process and diseases. The research she proposes entitled Computational
Methods for Inferring Single-cell DNA Methylation and its Spatial Landscape combines advanced spatial
transcriptomics techniques with computational methods to infer spatial DNA methylation landscape, which
enables the accurate evaluation of the epigenomic spatial variability and epigenomic targets in therapy for
diseases. Dr. Hou completed her PhD in Mathematics at The University of Hong Kong where she focused on
inferring and controlling gene regulatory networks (GRNs). Her ﬁrst postdoctoral research (2017-2019) with Drs.
Aravinda Chakravarti and Suchi Saria at Johns Hopkins University (JHU) represented the ﬁrst shift in focus of
GRNs from theoretical to computational genomics. Her second postdoctoral research (2019-present) with Drs.
Hongkai Ji and Stephanie Hicks at JHSPH has further provided complementary training in reconstructing and
predicting spatial transcriptomic and epigenomic landscape using single-cell data. Dr. Hou's mentoring team
consists of Hongkai Ji (primary mentor), PhD, an expert in developing computational and statistical tools for
analyzing single-cell genomic data, including reconstructing and predicting temporal and spatial transcriptomic
and epigenomic landscape; Stephanie Hicks (co-mentor), PhD, an expert in developing statistical methods to
address technical variability and spatial transcriptomics in single cells; and Andrew Feinberg (co-mentor), PhD,
one of the founders of the ﬁeld of cancer epigenetics who directs the ﬁrst NIH funded Epigenome Center. This
offers the opportunity to tackle signiﬁcant challenges in the intersection of statistics, epigenomics and spatial
transcriptomics with advanced experimental techniques. Her scientiﬁc advisors are Drs. Kasper Hansen,
Gregory Hager and Xiaobin Wang who have leading expertise in computational epigenomics, deep learning,
clinical translation and disease prevention, respectively. Leveraging the intellectual, experimental, and computing
resources from all mentors and advisors as well as through JHSPH, JHU and Johns Hopkins Medicine, Dr. Hou
will receive intensive training, mentoring and career development to achieve the goals proposed in this
application and have productive outcomes during the award period. Aim 1 will develop methods to predict DNA
methylation landscape using bulk gene expression. Aim 2 will develop methods to predict single-cell DNA
methylation and differential DNA methylation. Aim 3 will reconstruct tissue-spatial DNA methylation landscape at
the single-cell level, generate evaluation datasets in spatial context, and perform across-study assessments
using data from The Encyclopedia of DNA Elements (ENCODE), Human Cell Atlas, and Recount2.

Public health relevance
Project Narrative Genomic and epigenomic abnormalities collaborate in disease initiation and progression, as exempliﬁed by frequent mutations in protein-coding genes which can vary spatially in separated sub-regions of tissues. This project will develop computational methods to infer tissue-spatial epigenomic landscape which can not be measured using current techniques, leveraging the emerging technologies of spatial transcriptomics, and develop novel statistical methods to identify differential epigenomic signals across patients or cell populations. The outcome of this project can lead to the development of new epigenetic targeted therapy and new epigenetic therapeutic drugs for various diseases that helps the broad community.